High-throughput Phenotyping of iPSC-derived Airway Epithelium by Multiscale Machine Learning Microscopy

PROJECT SUMMARY/ABSTRACT
Challenges. The airway epithelium consists of various cell types – understanding cellular and functional
heterogeneity will have a significant impact on diagnosing and treating diseases. However, few analytical tools
are available to investigate spatiotemporal phenotypes of these cells on a global population scale.
Conventional high-throughput microscopy (HTM), although powerful for dissecting heterogeneous biological
processes, is significantly limited in multiscale imaging and analytics. Most HTM systems are constructed by
combining high-magnification microscopes with scanning stages; this configuration would entail high
complexity in the system design and operation, high cost, and slow image acquisition rates. Follow-on data
analyses, based on traditional ensemble averaging approaches, often lead to the loss of detailed mechanistic
information. Innovations. We will advance a “smart” imaging platform, M3 (Multiscale Machine-learning
Microscopy) for large-scale, live-cell analyses. M3 will integrate cutting-edge breakthroughs: Fourier
ptychographic microscopy (FPM) and deep learning (DL). FPM is based on a spatially coded-illumination
technique, collecting low-resolution image sequences while changing the position of a point-light source. These
images are then numerically combined to restore the whole Fourier space, allowing FPM to achieve both wide
field-of-view and high spatial resolution simultaneously. DL is potent in discovering intricate, hidden structures
in high-dimensional data sets with limited human supervision. We will integrate DL with time-series modeling to
learn disease-related cellular traits. Goals. We will implement the M3 platform and adopt it to analyze cellular
phenotypes during airway epithelium development. Aim 1. We will construct the M3 imaging system based on
the FPM technology. This system will feature i) a new numerical algorithm to reconstruct 3D volumetric images
and ii) multi-color imaging capacity for molecular detection. Aim 2. We will advance a DL framework for M3
image analyses. This framework will be designed to recognize different cell types and learn their
spatiotemporal features to unravel multiscale cellular heterogeneity. Aim 3. We will apply M3 to phenotype
cells in the airway epithelium. We will use an in-vitro model that uses induced pluripotent stem cells (iPSCs) to
derive lung epithelium. M3 will monitor cellular differentiation during epithelium development and examine the
correlation between cellular phenotypes and functionals. Impact. The M3 will bring unprecedented analytical
power to characterize diverse cells within the airway epithelium, allowing us to discover many hidden
phenotypes in cellular and tissue levels. Such knowledge would have implications for early disease detection
as well as designing effective therapeutics.

Public health relevance
NARRATIVE We propose to develop a novel multiscale machine-learning microscopy platform for automated, large-scale analyses of single cells. By integrating new computational optics with deep learning, this new system will enable high resolution (0.4 μm) and large field-of-view (10 mm2) volumetric imaging and automatically identify hidden phenotypes from millions of single cells. We will apply the developed technology to map out the live cell phenotypes in iPSC(induced Pluripotent Stem Cell)-derived airway epithelium.